Experiences of Rural Sexual and Gender Minority Couples: Does Alcohol Use Explain the Link Between Minority Stress and Intimate Partner Discord and Violence

PROJECT SUMMARY/ABSTRACT
Alcohol use and destructive couple conflict, including intimate partner violence (IPV), represent dual public
health threats for sexual and gender minorities (SGM), who experience higher rates of these problems than
their cisgender, heterosexual counterparts. Although a broader literature links alcohol use to increased rates of
destructive couple conflict, very little work has examined these associations in SGM couples. Here, we draw on
alcohol myopia theory and propose that increased daily alcohol use will be associated with higher same-day
levels of destructive conflict among SGM couples. Further, we predict that greater drinking to cope motives and
higher levels of internalized minority stress (i.e., fear of rejection, worry about concealment, internalized
homophobia/transphobia) assessed at baseline will exacerbate the effects of daily minority stress (exposure to
discrimination, harassment, and stigmatization) on alcohol use and subsequent destructive conflict.
Importantly, these processes will be examined in a sample of SGM couples residing in the rural Midwest—a
population that is critical to study because of the increased types and frequency of stigma encountered by
SGM individuals living in rural areas as compared to more urban locations. Finally, we test the hypothesis that
the detrimental impact of minority stress on alcohol use and destructive couple conflict will be mitigated by
greater (a) social support from interpersonal relationships, (b) psychological sense of connection with the
LGBTQ+ community, and (c) psychological sense of community with one's rural Midwestern neighborhood.
Participants will be 200 SGM couples (i.e., both individuals identify as lesbian, gay, bisexual, transgender,
and/or queer, and are in a committed intimate relationship). Couples will be recruited from the Midwestern
LGBTQ+ Research Registry, established by the MPIs. Our proposed models will be tested using intensive
daily diary methods employed over 60 days to track daily experiences of minority stress, alcohol use, and
destructive conflict. Findings from this project will provide novel data about the conditions under which daily
minority stress contribute to elevated levels of destructive couple conflict via increased alcohol use by rural
SGM couples. Our examination of support and community-based resiliency factors will highlight potential
points of intervention that can be targeted to interrupt the harmful effects of minority stress on alcohol use and
subsequent intimate partner conflict and violence.

Public health relevance
PROJECT NARRATIVE The proposed research is focused on understanding the public health impact of daily experiences with discrimination, harassment, and stigmatization experienced by sexual and gender minority couples living in rural communities in the Midwest. We aim to isolate key factors that increase the likelihood of alcohol use and destructive conflict in response to distress experienced from daily minority stress (i.e., drinking to cope motives and internalized forms of minority stress). We will also identify sources of resiliency arising from interpersonal relationships and community-based resources that interrupt this maladaptive cascade and mitigate risk for the dual public health threats of alcohol use and intimate partner violence in this underrepresented population.